DENDRITIC SPINES: QUANTITATIVE MPE CALCIUM UNCAGING TO DEEP TISSUES

30 Oct 98 to 25 Nov 98 Test and demonstration of remote biomedical video conferencing in collaboration with Cornell University Medical College. On site planning at CUMC and main campus